Texas Center for Minority Health, Education, Research and Outreach

Project Summary-Overall
Despite the overall improvement in the health of Americans during the past three decades, significant
disparities in health outcomes persist based on race and ethnicity, sex, level of education and income,
and other social characteristics. There is a growing awareness in many segments of United States
society that persistent health disparities are not acceptable, and that through coordinated and targeted
actions most health disparities are correctable. Created in 2005 with funding as an EXPORT Center,
and current funding as a NIMHD Center of Excellence (P20), the Texas Center for Health Disparities
(TCHD) has been a leader in health disparities research, education, and outreach in its local
community, throughout the State of Texas, and in many parts of the nation. Building on its significant
experience and expansive relationships, the TCHD proposes the NIMHD Specialized Center of
Excellence (COE) with a focus on Women’s Health Disparities. Consistent with the community-based
participatory research (CBPR) focus of the TCHD, the focus area was identified through substantial
community dialogue with partners. We will employ translational and CBPR approaches for identifying
developing detection and therapeutic strategies for triple negative breast cancer, testing a patient-
centered, community pharmacy-based comprehensive medication therapy management for HIV
patients and an intervention to improve health behavior among women in underserved communities.
Our COE will augment and strengthen the existing infrastructure and capacity of the TCHD for
conducting basic, clinical, translational, participatory, and socio-behavioral research consistent with the
NIMHD Research Framework. Our focus on Women’s Health Disparities will address a significant need
among racial and ethnic minority women in the U.S., the State of Texas, and our local community. We
will also expand and develop new education and community engagement activities with our partner
institutions and community. The objectives of our COE are to: 1) Conduct CBPR based- and
biomedical- research on health disparities in women’s health that exists in Texas minorities such as
cancer, HIV, obesity, cardiovascular diseases, and stroke, 2) Provide opportunities for junior faculty,
postdocs and early stage investigators to train in health disparity research that meets the community
needs, 3) Promote education of students in health professions, health care practitioners and policy
makers on the existence of health disparities and the need to combat the problem, and 4) Serve as a
resource for the minority communities in North Texas to disseminate health information, promote
community participation in health education and research, and to implement disease prevention
activities.

Public health relevance
Project Narrative The goal of the Texas Center for Minority Health, Education, Research and Outreach program is to utilize NIMHD COE funding to build capacity and infrastructure at the UNTHSC for its nationally recognized health disparities research, training and outreach activities, specifically in recruiting and training more junior faculty, postdocs and earlystage investigators in research on minority health and health disparities. The Center will enable transdisciplinary, interprofessional collaborations and novel approaches to understanding minority health and eliminate health disparities.